Self-Assembling Camptothecin Nanofiber Hydrogels as Adjunct Therapy for Intraoperative Treatment of Malignant Glioma

Project summary
Malignant gliomas, including the most common type glioblastoma (GBM), are histologically heterogeneous and
invasive tumors known as the most devastating neoplasms with high morbidity and mortality. Despite multimodal
treatment including surgery, radiotherapy, and chemotherapy, the disease inevitably recurs and proves fatal.
Local application of carmustine implants (Gliadel® wafers) as an adjunct to surgery and radiation therapy has
been clinically proven to extend the survival time for patients with malignant gliomas, strongly suggesting that
local chemotherapy after tumor resection presents a feasible and effective strategy to treat brain tumor
patients. However, the rapid depletion of carmustine and low tissue penetration greatly limit the clinical benefits
of Gliadel® wafers, which only extend the median survival of treated patients by six months compared to those
untreated. This proposal aims to develop a novel type of self-assembling nanofiber hydrogels that use the
anticancer drug camptothecin (CPT) as the molecular building blocks and that can be locally administered to the
resection cavities after tumor removal, with the ultimate goal to achieve more effective treatments for patients
diagnosed with malignant gliomas. We hypothesize that the proposed nanofiber hydrogels will spread across
large tissue areas and sustainably release therapeutic agents for long-term cytotoxicity against glioma cells, thus
leading to significantly extended survival time in our rodent model. To test our hypothesis, we outlined the
proposed research activities in the three specific Aims, seeking to address the three key challenges in local
delivery of therapeutic drugs into resection cavities: 1) the nanofiber gelation properties. The gel form enables
prolonged retention in the delivery sites and also minimizes capillary loss of free drugs that would otherwise
occur; 2) the sustained release of free drugs over a long period of time. The release rate and period are
critical for effective elimination of glioma cells without causing devastating side effects; 3) diffusion across large
tissue areas. In Aim 1, we will identify the key molecular parameters in the design of self-assembling CPT DAs
to create CPT nanofibers of varying surface chemistries that would promote the formation of hydrogels upon
contact with body fluids. Aim 2 is focused on the evaluation and fine-tuning of the drug release rate and
mechanism, their ability to overcome the MDR mechanisms, as well as diffusion distance within organotypic
tissues. In Aim 3, we will use an animal model to evaluate the nanofibers’ ability to diffuse across large tissue
areas, pharmacokinetics, in vivo efficacy and toxicity of two already developed nanofiber hydrogels and also
those to be developed in Aim 1 and Aim 2. Our ultimate goal is to develop a nanofiber hydrogel platform
technology that will extend the survival time of rodents bearing human brain cancer, and translate this platform
to a pre-clinical approach.

Public health relevance
Project narrative (relevance) One of the greatest hurdles to prolonging survival in patients with malignant brain tumors is the inevitable tumor recurrence in the vicinity of the original location or the resection cavities despite multimodal treatment including surgery, radiotherapy, and chemotherapy. We aim to develop a camptothecin drug amphiphile (DA) nanofiber hydrogel platform technology as adjunct therapy for intraoperative treatment of malignant brain cancer that can eradicate infiltrated glioma cells by maintaining a therapeutic concentration within the brain while minimizing systemic drug exposure. This goal will be achieved by evaluating and optimizing our current hydrogel- forming DA technology with in vitro, ex vivo and in vivo brain tumor models well-established in our laboratory, and the results of our study will validate a new local treatment strategy to combat currently incurable brain cancers with significant survival benefits and good tolerance.